Proteogenomics Core

Summary
For COBRE Phase II, the Center for Translational Pediatric Research (CTPR) will support a new
Proteogenomics Core that is essential for the research mission of the center. The Proteogenomics Core is a
unique, new core that will provide services that are not duplicative of those existing at the institution.
Proteogenomics is defined as the integration of proteomics with genomics and transcriptomics. This new core
will provide center members’ access to experienced personnel for non-standard proteomic, genomic, and
epigenomic applications, and access to highly skilled bioinformaticians for cutting-edge data analysis and
integration. The Proteogenomics Core will be directed by Dr. Stephanie Byrum, who brings a wealth of
experience leading successful core facilities and who is nationally-recognized as a leader in the field. This new
Proteogenomics Core will have state-of-the-art equipment for proteogenomics applications and staff for
sophisticated data integration strategies. Our short-term goal for COBRE Phase II is to provide resources needed
to develop this new Proteogenomics Core, which will provide essential research services needed for center
members and other researchers. Our long-term goal during Phase III, and beyond, is to position this new core
for long-term sustainability through establishing a recharge mechanism and serving as a core in future program
project grants submitted by CTPR investigators. For this proposal, our objective is to develop a new COBRE
Proteogenomics Core that will provide highly-specialized proteogenomics support and educational opportunities
for current and future COBRE Research Project Leaders and other center members. To achieve our objective,
we will pursue the following Specific Aims: (1) Develop a new COBRE Proteogenomics Core for highly-
specialized, non-standard proteogenomics data collection and analysis for COBRE Research Project Leaders
and other center members and (2) Provide resources and educational workshops to support COBRE Research
Project Leaders and other center members.